Addressing the Research Capacity Gap in Global Child, Adolescent, & Family Health Utilizing Implementation and Data Sciences

PROJECT ABSTRACT
Significant advances in global health have been achieved in recent decades. Yet, serious variances in health
outcomes persist, especially among children, adolescents and their adult caregivers. Sub-Saharan Africa (SSA)
is one of the regions disproportionately burdened by multiple health threats, including endemic CDs; emerging
and re-emerging infectious diseases; increasing incidence of NCDs, and a set of exacerbating factors that have
contributed to poor public health and increased overall disease burden affecting children, adolescents and their
adult caregivers. Similar trends are documented in several other LMICs, including countries in Asia and Eastern
Europe. In light of widespread health challenges and gaps in the translation and uptake of scientific evidence in
real-world settings in LMICs, dissemination and implementation science can advance timely and context- specific
public health solutions. Moreover, significant methodological advances in data science can create new
opportunities to more accurately identify sensitive populations, better understand patterns and mechanisms of
health burdens, and allow for more in-depth analysis of implementation gaps and imbalances in healthcare
systems and across populations in LMICs. The proposed research training program, entitled “ACHIEVE:
Addressing the Research Capacity Gap in Global Child, Adolescent & Family Health Utilizing
Implementation and Data Sciences”, focuses on increasing dissemination and implementation science and
data science capacity to address global health issues affecting children, adolescents and their adult caregivers.
The program addresses the following specific aims: Aim 1: To provide a research training program to five cohorts
(~50 trainees) of health care professionals and post-doctoral trainees from the U.S., and post-professional degree
graduates from SSA that equips trainees with dissemination and implementation and data science research skills
and knowledge through experiential learning, mentoring, “hands-on” immersion in global health implementation
and data science research and methodologies, individualized consultation, goal setting and monitoring and web-
based support across time; Aim 2: Bring together an interprofessional network of committed mentors from the
global north and the global south to promote bi-directional learning and collaboration and ensure quality training for
promising new investigators committed to applying dissemination and implementation science and data science
research methods to address health gaps impacting children, adolescents, and their families in low-resource
settings; Aim 3: To examine the short-term and longitudinal outcomes of the ACHIEVE training program; and
Aim 4. Delineate key factors that underlie successful mentorship and training of new investigators– with potential
implications for new investigators who are focused on dissemination and implementation science and data
science research that seek to address health gaps impacting children, adolescents, and their adult caregivers.

Public health relevance
PROJECT NARRATIVE While significant advances in global health have been achieved in recent decades, serious variances in health outcomes persist, especially among children, adolescents and their adult caregivers. The proposed research training program in global health research, entitled “ACHIEVE: Addressing the Research Capacity Gap in Global Child, Adolescent & Family Health Utilizing Implementation and Data Sciences focuses on increasing dissemination and implementation science and data science research capacity in order to address global health challenges affecting children, adolescents and their adult caregiving families; and is designed for Medical Doctors and Post-Doctoral trainees in the United States ) and sub-Saharan Africa. The ultimate goal of the ACHIEVE program is to support the development of a cadre of early career researchers applying dissemination and implementation science and data science research methods to ensure that research on evidence-based practices, interventions, and policies are effectively translated to and used in real-world settings heavily affected by health challenges impacting children, adolescents, and the adults who raise them in low and middle-income countries.